Health Disparities Core

The OAIC will support research in older adults with serious illness (OASI) and geriatric palliative care
(GPC). New with this renewal is a core on health disparities--Resource Core-Health Disparities (RC-HD)--that
builds on a foundation of work from previous cycles. RC-HD will support research that will advance our
understanding of health disparities in the longitudinal course of OASI and their care partners. Much of this work
builds on our experience using national population-based studies and health system data, but we will also
support OAIC investigators with projects that may involve other data or qualitative methods. The RC-HD will
establish a new resource to help investigators extend and realize the OAIC’s objectives. This new core will
complement and collaborate with the Research Methods and Measurement (RC-RMM) and Population Data
Management (RC-PDM) Cores’ analytic and methodologic resources by providing support to OAIC
investigators on research in health disparities.
RC-HD will accomplish this work through the following specific aims: 1) to integrate health disparity
research expertise across all MS-OAIC cores; this will include providing primary support for three External
Projects (EP); 2) to collaborate closely with the Research Education Component (REC) to foster the training
and development of early and mid-career scientists and to apply a disparity-centered approach throughout the
research process; this will include a pilot to match aging-related NIH principal investigators with junior
investigator candidates; 3) to create new knowledge and resources to support the conduct of rigorous research
to address disparities in the care of older persons with serious illness across different populations; this will
include collaborating with the other RCs in the work of two DPs using the Medicare Current Beneficiary Survey
that will create datasets and methods that can be disseminated and used by investigators; and 4) to work with
and participate in Mount Sinai programs focused on reducing health disparities in palliative care, in cancer, and
in geriatrics, to coordinate for community engagement, to review REC and projects supported, and to advise
on the overall direction of RC-HD.
Through integration of health disparity expertise across all of MS-OAIC’s activities, fostering the
development of GPC scientists, and actively engaging national partners, RC-HD will address disparities in the
care of older adults with serious illness through rigorous scientific inquiry and dissemination of evidence that
promotes access to high-quality care for all older adults with serious illness.